Psychology Training in Alcohol Research (PTAR)

PROJECT SUMMARY/ABSTRACT
The purpose and objectives of this training grant are to provide training in alcohol research for pre and
postdoctoral trainees in psychology and related disciplines. This training program has been successfully
producing skilled alcohol research scholars for the past 34 years. The training program provides quality
research training in the combined areas of etiology, prevention, and treatment of alcohol use disorders. Alcohol
research training is approached from both psychosocial and bio-behavioral perspectives. Psychology is in a
unique position to provide this combined emphasis as the field encompasses a number of specialty areas that
bear directly on the study of alcohol, and bridge to other key disciplines relevant to alcohol research. The
training faculty includes representatives from each of these specialty areas from several departments across
the university. Faculty include 28 individuals with appointments primarily within Psychiatry and Psychology,
who provide apprenticeship training and research supervision for trainees. Funds are requested to support 5
postdoctoral and 3 pre-doctoral trainees each year. Trainees will participate in the required Addictive Behaviors
Core curriculum, which involves a series of courses and seminars in the field of alcohol and addiction research,
as well as a grantsmanship/career development seminar designed to promote the transition to independence.
Pre-doctoral trainees are also required to complete a core curriculum consistent with departmental
requirements for a Ph.D. Required courses include: (1) statistics and general methodology, (2) a major area of
study in clinical, physiological, developmental, experimental, behavioral and molecular neuroscience, animal
behavior, or health psychology, or closely related areas approved by the training faculty; (3) breadth
requirements intended to assure broad exposure to other areas of psychology, and (4) out of area coursework
relevant to the study of alcohol use disorders and addictive behaviors. Trainees in the course of the program
will be expected to (a) acquire research methodologies relevant to the alcohol field with both human and
animal subjects; and (b) apply such skills and knowledge in the design and execution of both basic and applied
research related to the etiology, prevention, and treatment of alcohol misuse and alcohol use disorder.

Public health relevance
NARRATIVE This highly successful alcohol research training program will allow trainees to gain the knowledge and skills needed to (1) research the etiology of alcohol misuse and alcohol use disorders, involving both animal and human research studies, and (2) develop effective assessment, prevention and intervention approaches for alcohol use disorders. Trainees are explicitly trained in integrating diverse research methodologies and perspectives to address the complex and costly public health problems posed by alcohol misuse and alcohol use disorder.